Structural basis of Rho glucosylation by Clostridium difficile toxins

Abstract
Clostridium difficile, a Gram-positive, anaerobic, sporogenic bacterium, is often seen in severely ill or
elderly patients in hospitals or in long-term care facilities. Clostridium difficile infection (CDI), which is the most
common cause of antibiotic-associated diarrhea in developed countries, is primarily caused by two
homologous exotoxins, TcdA and TcdB. These toxins target and disrupt the colonic epithelium, leading to
diarrhea and colitis through receptor mediated endocytosis. TcdA (~308 kDa) and TcdB (~270 kDa) contain
four functional domains: an N-terminal glucosyltransferase domain (GTD), a cysteine protease domain (CPD),
a central transmembrane delivery and receptor-binding domain (DRBD), and a C-terminal combined repetitive
oligopeptides (CROPs) domain. It is widely accepted that the toxins bind to cell surface receptors via the
DRBD and the CROPs, and enter the cells through endocytosis. Acidification in the endosome triggers
conformational changes in the toxins that prompt the DRBD to form a pore and deliver the GTD and the CPD
across the endosomal membrane. In the cytosol, the CPD is activated by eukaryotic-specific inositol
hexakisphosphate and subsequently undergoes autoproteolysis to release the GTD. The GTD then
glucosylates small GTPases of the Rho family, including Rho, Rac, and Cdc42. Glucosylation of Rho proteins
inhibits their functions, leading to alterations in the actin cytoskeleton, cell-rounding, and ultimately apoptotic
cell death. Therefore the GTD is an ideal molecular target for therapeutic interventions, which directly targets
the root cause of disease symptoms and cellular damage in CDI. While the relative roles of these two toxins in
the pathogenesis of CDI are not completely understood, TcdB is considered to be more virulent than TcdA and
more important for inducing the host inflammatory and innate immune responses. Therefore, we will focus on
TcdB in this project, and the goal of this proposal is to understand the molecular mechanism by which TcdB
covalently modifies its substrates, Rho family GTPases, by glucosylation. We propose two specific aims: (1) to
understand the structural basis for recognition of Rho GTPases by the GTD, and (2) to understand the affinity
and specificity requirements for the GTD–Rho recognition. We will use X-ray crystallography and structure-
based mutagenesis to examine interactions between the GTD and Rho proteins at the molecular level, as well
as to reveal the structural determinants of substrate specificity and vulnerabilities of the GTD. These findings
will provide new insights into the function of the GTD and the pathogenicity of TcdB, which could guide the
design of novel therapeutic reagents to treat CDI by inhibiting the activity of the GTD.

Public health relevance
Public Health Relevance Clostridium difficile toxin A (TcdA) and toxin B (TcdB) are responsible for diseases associated with C. difficile infection (CDI). Here we seek to understand the molecular mechanism by which TcdB covalently modifies its substrates, Rho family GTPases, by glucosylation. The accomplishment of our goal will provide new insights into the function of the glucosyltransferase domain of TcdB and its pathogenicity, which could guide the design of novel therapeutic reagents to treat CDI.